Neural Mechanisms of Spatial Auditory Attention with Magnified Interaural Level Differences

PROJECT SUMMARY/ABSTRACT
Everyday listening requires auditory selective attention: the ability to direct attention to a single sound source
(e.g., your friend talking to you) amongst competing sources (e.g., other patrons at a restaurant). Spatial
information is particularly useful for identifying and directing our attention toward a sound source, and the
perceptual benefit we receive from the spatial separation of sound sources is called spatial release from
masking (SRM). Two pieces of acoustic information are useful in SRM: (1) the difference in the time of arrival
of a sound between the two ears, or the interaural time difference (ITD), and (2) the difference in the intensity
level of the sound at the two ears, or the interaural level difference (ILD). Normal hearing (NH) listeners rely
on both ITD and ILD information to successfully deploy spatial auditory selective attention. However, bilateral
cochlear implant (BiCI) users do not have robust access to ITDs, as their devices do not provide temporal
information at a fine enough grain. Since ITDs are considered the dominant spatial cue, BiCI users demonstrate
poorer spatial hearing outcomes than their normal hearing peers. Instead, they must rely on ILDs. In this project,
we propose to remediate spatial hearing in BiCI users through ILD Magnification. This strategy enhances
source lateralization by applying larger-than-natural ILDs. ILD Magnification has been shown to improve
performance on spatial hearing tasks in both NH listeners listening to vocoded sound and BiCI users, but the
neural mechanisms underlying this benefit remain unclear. Here, we will test whether ILD magnification provides
a benefit to sound source segregation or to spatial selection. We will measure known neural signatures of
auditory attention using functional near-infrared spectroscopy (fNIRS) and electroencephalography (EEG) while
subjects complete a spatial attention task. These experiments will be conducted both in NH listeners (Aim 1) and
BiCI users (Aim 2). These two aims will affirm the perceptual benefits of ILD magnification and identify the neural
mechanisms underlying these benefits. This project offers essential training opportunities for the proposed fellow
in his career as an auditory neuroscientist. This includes gaining experience in fNIRS and EEG data collection,
as well as proficiency in signal processing and statistical analysis. Additionally, there will be hands-on experience
in recruiting and working with cochlear implant patients and exposure to clinical procedures. The training will
also encompass professional development, including teaching, mentoring, and science communication. The
proposed work will contribute substantially to our knowledge of the relationship between spatial acoustic
information and networks of auditory attention. Simultaneously, this project introduces a new method for
improving spatial hearing outcomes in bilateral cochlear implant users, working toward the NIH's goal of the
application of knowledge to improve health. Overall, the studies described here will improve our understanding
of the neural mechanisms underlying spatial hearing and implement a possible solution for those with cochlear
implants.

Public health relevance
PROJECT NARRATIVE Spatial auditory attention, crucial for focusing on a particular sound amidst multiple competing sources, is hampered in individuals with bilateral cochlear implants. This project proposes a sound processing strategy that magnifies spatial information, thereby aiding the brain in distinguishing between two sound sources. Through this work, we seek to deepen our comprehension of the neural processes involved in spatial hearing while offering a potential remedy for cochlear implant users.